Role of GH on thiol metabolism, stress resistance and aging

PROJECT SUMMARY The short term objectives of this KO2 proposal are: 1) to increase the time devoted to conduct and complete experiments of a recently awarded RO1; and 2) to complete exercises designed to enhance and enrich the applicants focus and expertise in the areas of aging and epigenetics. The long-term objective of the KO2 is to effectively utilize both 1) and 2) to enhance the training of graduate students, post docs, faculty (not currently practicing in the field of aging) and undergraduates, in particular, in aging research and to obtain additional support in future years. The research environment at the University of North Dakota School of Medicine & Health Sciences is active and growing. Two major NIH grants (INBRE, COBRE) over the last 8 years have increased the resources available to the basic scientists. The Proteomics/Mass Spectrometry core, a core in Bioinformatics that is under development and the Center for Biomedical Research (animal facilities) will be utilized by the applicant. The applicant has developed an active research program at UND with the current tools available and plans to increase those activities during the period of the award and beyond. The objective of the science integral to this proposal is to delineate mechanisms of the beneficial effects of growth hormone deficiency on mitochondrial function, stress resistance and health span. Our research has been focused on understanding the hypothesis that in long living animals, an upregulation of thiol metabolism leads to greater protection from cellular stress. The applicant's work has established that reduced growth hormone (GH) signaling is a major player in longevity assurance. The global hypothesis to be tested is that thiol metabolism plays a key role in aging and that GH modulates key components of this pathway ultimately leading to changes in health span (via stress resistance/protection) and lifespan. Thus, reduced GH signaling confers a biologic advantage to dwarf mice leading to better scavenging of toxic metabolic byproducts, altered mitochondrial function and enhanced longevity. To further address and define this global hypothesis the applicant plans to elucidate the relationship between GH, thiol metabolism and cellular protection by: 1) directly linking the enhanced respiratory and antioxidative activities in dwarf mice to increased mitochondrial GSH and glutathionylation of these proteins; 2) providing direct evidence that the lack of GH is responsible for substrate-specific enhancement of the GST system; 3) defining the changes in thiol metabolism linked to stress resistance and longevity following altered dietary MET; and 4) establishing the first epigenomic profile of a long-living mouse. Determining GH-dependent pathways and mechanisms may suggest therapeutic interventions to enhance stress resistance, delay aging, treat aging-related disorders and extend health span in humans.

Public health relevance
Project Narrative This KO2 proposal is designed to provide protected time for research and training and to enrich the applicants' science in the areas of aging and epigenetics. This protected time will be used towards the successful completion of experiments designed to determine the influence of growth hormone on processes related to stress resistance and longevity using two long-living mouse strains, Ames dwarf and growth hormone receptor knockout mice. Determining GH-dependent pathways and mechanisms may suggest potential therapeutic interventions to delay aging, treat aging-related disorders and extend life span in humans. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The applicant's research is focused on understanding the mechanism/s regulating aging of the human species. The applicant's approach has been to analyze the aging process in a mutant mouse model, called the Ames dwarf, that has a significantly increased lifespan compared to its control (1). The applicant's research has been focused on understanding and expanding the hypothesis that in long-living models, upregulation of glutathione (GSH) and other thiol-containing proteins leads to greater organism resistance to a variety of cellular stressors. The applicant's research has helped to form and extend a compelling link between the growth hormone (GH) and insulin-like growth factor (IGF1) signaling pathways in the aging process (2-10). The global hypothesis is that thiol metabolism plays a key role in the aging process and that GH modulates key components of this metabolic pathway ultimately leading to changes in health span (via stress resistance/protection) and lifespan. To further address and define this global hypothesis, two working hypotheses will be addressed in this proposal, both of which focus on the relationship between GH, thiol metabolism and aging. The first is that the susceptibility of mitochondria to ROS damage and other molecular insults is controlled by mechanisms that involve GH and thiol (glutathione) metabolism including protein S-thiolation, GSSG accumulation and glutathione-S-transferase (GST) expression. The second is that thiol metabolism and DNA methylation patterns are partially determined by circulating GH levels and the amount of dietary methionine. The innovative nature of this project is that the applicant will elucidate the relationship between GH, thiol metabolism and stress resistance in aging by: 1) directly linking the enhanced respiratory (OXPHOS) and antioxidative activities previously observed in dwarf mice to increased mitochondrial GSH and glutathionylation of respiratory and antioxidative proteins; 2) providing direct evidence that the lack of GH is responsible for substrate specific enhancement of the GST system in long-living mice; 3) defining the changes in thiol metabolism linked to stress resistance and longevity following altered dietary methionine in GH mutant mice; and 4) establishing the first epigenomic profile of a long-living mouse with a focus on genes related to mitochondria and stress resistance. This will be accomplished by completion of 4 specific aims. Aim 1: To test the hypothesis that GH affects the regulation of mitochondrial GSH, the glutathionylation status of proteins (specifically respiratory and antioxidative proteins) and the factors that regulate this process (glutaredoxin and thioredoxin) in tissues of Ames, growth hormone receptor knockout (GHRKO) and wild type mice. Aim 2: To test the hypothesis that GH affects the functional capacity of the GST system through regulation of specific GST family members in Ames dwarf, GHRKO, GH transgenic and wild type mice. Aim 3: To test the hypothesis that thiol metabolism is altered in GH mutant mice following changes in dietary methionine (both restriction and enhancement) leading to altered expression of proteins involved in stress resistance and lifespan. Aim 4: To test the hypothesis that GH affects DNA methylation of mitochondrial and stress resistance genes through regulation of thiol metabolism levels in long-living Ames dwarf and wild type mice. )